Mechanisms of vesicle trafficking and kinesin regulation

PROJECT SUMMARY
Nearly every aspect of cellular function—from development to metabolism and signaling—requires that
membrane proteins be targeted to the correct location in the cell. This process requires high specificity as
different cargoes are destined for different destinations. Although the basic steps of this process are known (i.e.,
cargoes are sorted into vesicles, the proper kinesins are recruited, and kinesins then transport vesicles to the
proper destination), our current understanding of the mechanisms by which kinesins are recruited to vesicles
and how their action is regulated on vesicles in live cells is extremely limited. Previously, the field lacked many
of the tools needed to better characterize and understand these mechanisms, but our group has developed
several cutting-edge tools that allow us for the first time to answer several fundamentally important questions. In
this project, we will apply our experience with these tools in combination with primary hippocampal neuron culture
and live cell imaging to achieve four key goals: 1) determine the mechanisms of on-vesicle regulation for kinesin-
mediated transport, using Kinesin-3 family member KIF13A as an initial model, 2) identify molecular links
between cargo sorting and kinesin recruitment, 3) determine the mechanisms that underlie the sorting of
polarized cargoes at the trans-Golgi network, and 4) develop additional molecular tools in pursuit of these goals
that also have applicability to the broader trafficking community.

Public health relevance
PROJECT NARRATIVE Normal cellular function requires that proteins responsible for sending and receiving signals be transported from the place in the cell where they are produced to the places in the cell where they are needed. It is known that a group of specialized proteins called kinesins is responsible for transporting proteins to the correct location, but the current understanding of how the right kinesin is paired with a particular protein and how they are directed to the right location is largely unknown. This project is designed to answer these questions, with the long-term goal of informing additional research on the roles of these proteins in preserving human health or contributing to disease.